Research Education Core (REC)

Research Education Core
Since the inception of the CCNY-MSK U54 in 2008, we have developed and implemented approaches to engage
and mentor students and early-stage investigators in cancer research. We have provided undergraduate and
graduate students with hands-on research experiences, developed cancer-related curricula, engaged students
in hands-on research experiences, and provided professional socialization and mentorship for students
appropriate to their academic level and career interests. We also provide individualized resources to ensure the
success of our ESIs and monitor their progress. The majority of students at CCNY, come from underrepresented
and underserved communities, and are socioeconomically disadvantaged. Many of our students are also first-
generation college students and/or from immigrant families and face immense competing demands that may
prevent them from choosing research careers. Our program is designed to provide opportunities for them to
successfully conduct biomedical and behavioral research at CCNY and MSK, and to provide mentorship and
guidance for career decision-making. Our overall goals are to: 1) Increase the number of competitively
trained, underrepresented students who enroll in MD, PhD or MD/PhD programs and, specifically, 2)
Increase the numbers of these students who pursue cancer-related research careers, and 3) Increase
the research competitiveness of Partnership ESIs. We will accomplish these goals by: (a) Providing
experiential activities and opportunities, support services and Partnership activities to enhance students’
engagement and performance in cancer-related research and professions; (b) Providing academic counseling,
advisement and mentoring to students to ensure that they are aware of the opportunities and prerequisites for
careers in cancer research; (c) Providing translational research experiences for each student prior to
graduation; (d) Providing career development resources for, and closely monitoring the progress of, ESIs; (e)
Conducting an evaluation to determine the results of all program activities and resource utilization; (f) Developing
and submitting proposals, e.g., through R25 mechanisms, to enrich th e sustainability of our educational and
training initiatives. In the next funding cycle, we will initiate new curricula with the Partnership Community
Outreach, Research, and Education/Engagement Core (PCORE) and the Linguistic and Cultural
Responsiveness Shared Resource Core (LCRSRC), which includes: 1) a Minor/Major in Medical Interpretation
and Translation in the Classical and Modern Languages and Literatures Department, 2) a Minor and Masters in
Health Equity in the Colin Powell School for Civic and Global Leadership, and 3) training for undergraduate and
master’s students in data science and artificial intelligence/machine learning (AI/ML) in the Grove School of
Engineering. These new initiatives will build a didactic, institutionalized platform for trainees to develop the
knowledge and research skills to address translational cancer health disparities and health equity.

Public health relevance
As per solicitation PAR-23-308 Comprehensive Partnerships to Advance Cancer Health Equity (CPACHE) (U54 Clinical Trial Optional) Project Narrative: Do not complete